Administrative Core

PROJECT ABSTRACT
The Administrative Core of the Rural Drug Addiction Research Center (RDAR) at the University of Nebraska will
coordinate the activities of a broad range of investigators and facilities, resulting in a better understanding of the
critical, emerging public health challenges posed by drug use in rural settings. The goal of the Administrative
Core is to lead, implement, and support RDAR’s evolution toward a sustainable, nationally recognized Center
dedicated to understanding the challenges and harms of rural drug addiction and developing appropriate
interventions. Toward this end, the Administrative Core will provide the skills, programmatic leadership, and
infrastructure necessary to ensure the Center functions efficiently, accomplishes its overall goals, and
responsively engages emerging research opportunities (Aim 1). It will also implement a comprehensive faculty
development plan to accelerate the transition of early career researchers to independent investigator status and
recruit and develop others to fill their places (Aim 2). The Administrative Core will support Center-affiliated
research projects conducting novel and collaborative investigations related to the Center’s programmatic focus
through access to the Longitudinal Networks Core (LNC) and implementation of a pilot grant program to develop
innovative research using LNC and other resources (Aim 3). In this process, it will lay the groundwork for the
submission of large, multi-investigator proposals to NIH on behalf of Center members. Center-sponsored
projects will address the problems of rural illicit drug use from a wide range of disciplinary perspectives, including
neuroscience, cognition and decision-making, simulation and epidemiology, and clinical research. The
Administrative Core will actively facilitate four strategies for synergy across RDAR projects,
including: 1) coordinating interdisciplinary activities such as a mandatory monthly seminar, an annual translation
symposium, and collaborative grant development workshops; 2) providing a common research space for Center
members and their teams; 3) facilitating the use of a coordinated data collection strategy; and 4) maintaining a
regular schedule of Center meetings in which collaboration planning will be a regular agenda item. Through
these coordinating functions, RDAR will enable a critical mass of investigators, postdoctoral fellows, graduate
students, and personnel to study rural drug addiction at the University of Nebraska. The Center’s Leadership
Team will receive ongoing guidance from an External Advisory Committee and an Internal Mentoring and
Advisory Committee, committees that will help guide Center strategy toward effectiveness and sustainability.
RDAR will also establish an experienced translation and dissemination team to maximize the broader impact of
Center-sponsored projects (Aim 4). Finally, RDAR will implement a robust and multilayered evaluation plan by a
federally certified evaluator. This overall structure is designed to maximize productivity of Center members and
the impact of RDAR’s scientific advances on this critical health issue.